Investigating the coordinated functions of a dual Ca2+ sensor system in C. elegans

SUMMARY
Information processing in the nervous system, essential for brain function, is predominantly
mediated by chemical neurotransmission. Since Katz and his colleagues first revealed that Ca2+
triggers ultrafast vesicle exocytosis at the presynaptic terminal, studies have focused on the roles
of the Ca2+ sensor proteins in this process. Biochemical, structural, and functional studies have
found that two members of the synaptotagmin protein family, synaptotagmin-1 and -7 (Syt1 and
Syt7), play critical roles in synaptic vesicle exocytosis by acting as primary and secondary Ca2+
sensors at many vertebrate synapses. Deletion of these Ca2+ sensors leads to severe synaptic
transmission defects, and mutations in Syt1 and Syt7 have been linked to multiple neurological
disorders. Despite the work done on synaptotagmins in rodents, a number of questions remain
unresolved regarding how dual Ca2+-sensors coordinate to regulate synaptic transmission. In the
last 20 years, the nematode C. elegans has been widely used to study the molecular and cellular
mechanisms of synaptic transmission, and exhibit remarkably well-conserved synaptic
machinery. Using behavioral and electrophysiological screens of synaptotagmin isoforms in C.
elegans, our recent work has shown that the worm NMJs also use a dual Ca2+ sensor system
(SNT-1 and SNT-3) to regulate neurotransmitter release. Loss of SNT-1 (the primary Ca2+
sensor) and SNT-3 (the secondary Ca2+ sensor) completely eliminate evoked release, while loss
of either alone, has differential effects. The fact that the dual Ca2+ sensor systems of worms and
mice share many similarities, allows us to study how synaptotagmins coordinately function at
synapses, using the strengths of C. elegans as a genetic model organism and our unique technical
expertise. In this project, we propose three aims to address how SNT-1 and SNT-3 work together
to regulate neurotransmission. Aim1 focuses on potential interactions between SNT-1/3 with
SNARE complexes and the plasma membrane. A number of highly conserved SNT-1and SNT-3
residues known to interface with SNAREs and the plasma membrane in vertebrates, will be
mutated to test their effects on SV fusion. Aim 2 will investigate spatial and kinetic aspects of
SNT-1 and SNT-3 function in coordinating synaptic release, and determine the interplay between
SNT-1, SNT-3 and the key priming factor UNC-13. In Aim 3, we will determine how SNT-1 and
SNT-3 regulate synaptic transmission under conditions of high release probability. The findings
should significantly expand our understanding of how dual Ca2+ sensor systems operate to meet
the demands of synapses under basal as well as elevated-release conditions.

Public health relevance
NARRATIVE Functional impairments of synaptotagmin Ca2+ sensors have profound effects on synaptic transmission and neuronal communication and have been implicated in various neurological conditions including autism, epilepsy, and neuromuscular junction (NMJ) disorders. Using the nematode C. elegans as a model, this project will focus on two synaptotagmin isoforms, SNT-1 and SNT-3, which act as a dual Ca2+sensor system, similar to that at vertebrate synapses, to investigate how they coordinate to control synaptic vesicle exocytosis and synaptic plasticity. Using a combination of electrophysiology, imaging, biochemistry, electron microscopy, and genetics, this project aims to determine the fundamental molecular and cellular mechanisms by which dual Ca2+-sensors regulate synaptic transmission.